Structures and mechanisms of circadian rhythms from cyanobacteria to humans

Project Summary
Circadian rhythms arise from genetically encoded clocks that are intimately linked to external cues like light to
synchronize physiology and behavior with the 24-hour solar cycle. Although the genetic networks that give rise
to circadian rhythms are now relatively well established, we still don’t understand many of the fundamental,
molecular steps that determine the ~24-hour basis of these clocks and how they respond to external time-setting
cues. By integrating structural biology and solution biophysical methods with biochemistry and cell biology, we
aim to determine the underlying biochemical principles that lead to the day-long timescale of circadian signaling
and uncover the mechanisms that allow biological clocks to faithfully maintain intrinsic timing and respond
robustly to external cues. With prior NIGMS funding, we studied clock systems from mammals and cyanobacteria
to discover how different clock proteins assemble into regulatory complexes and identified how protein dynamics,
enzyme activity and/or post-translational modifications impact clock timing. Our comparative biochemical
approach highlighted surprising commonalities, such as the competition for mutually exclusive binding sites,
between these clocks despite their different molecular architectures. Here, we will continue to pursue the
structural basis of protein assemblies from diverse biological clocks, determine the consequences of post-
translational modifications on clock protein function, study the molecular basis for entrainment of clocks to
external cues, and seek out new inroads for pharmacological intervention. Funding from the MIRA program
would provide us with the resources and flexibility to explore commonalities in mechanisms of biological
timekeeping across a diverse array of species from cyanobacteria to humans.

Public health relevance
Project Narrative The goal of this project is to develop an understanding of the detailed mechanisms by which clock proteins from diverse species generate circadian rhythms, used to align physiology and behavior with the day/night cycle for adaptive benefit. Bringing fundamental, molecular insight to the clock will facilitate the development of therapeutics that enhance the systemic synchronization of physiology and behavior to improve human health.